Intestinal bacteria and epithelial barrier disruption after alcohol and burn injury

Summary/Abstract
Nearly one million burn injuries are reported every year in the United States. Many of these injuries occur
under the influence of alcohol intoxication. Intoxication at the time of injury is associated with worse prognosis
in burn patients resulting in more adverse outcomes. Gut dysfunction is a common hallmark in post-burn
complications and thus studying ways to prevent gut dysfunction following burn injury bears strong clinical
relevance. We and others have shown that severe burn or moderate burn injury combined with ethanol
exposure disrupts the normal intestinal microbial structure and barrier integrity within 24 hours after injury, but
how these changes in the microbiome contribute to intestine barrier disruption and subsequent development of
post-burn complications remains to be established. An analysis of fecal samples from burn patients as well as
from mice that have undergone ethanol and burn injury show a decrease in beneficial bacteria, including those
involved in the production of helpful metabolites such as Short Chain Fatty Acids (SCFAs), and an increase in
pathogenic bacteria involved in the production of harmful metabolites such as trimethylamine (TMA), a
precursor of trimethylamine-N-oxide (TMAO) compared to controls. SCFAs such as butyrate play a key role in
intestinal barrier maintenance. Moreover, TMAO has been linked with vascular inflammation, leakage, and
poorer outcomes in patients suffering from cardiovascular diseases. Recently, we focused on microRNAs as
they regulate many cellular processes. We have found the expression of several miRNAs is altered in intestinal
epithelial cells (IECs) in mice receiving ethanol and burn injury. Together these findings led us to hypothesize
that “gut dysbiosis and associated changes in microbial metabolites (SCFAs and TMAO) drive
intestinal barrier disruption by altering miRNA homeostasis which can promote pathophysiological
complications in alcohol and burn injury”. The hypothesis will be tested using samples generated from
burn patients and a mouse model of ethanol and burn injury. Studies in Aim 1 will determine the changes in
gut microbial structure and their metabolites in patients with burn injury and evaluate whether alcohol has any
impact on these changes. Studies in Aim 2 will determine whether re-introduction of probiotics in mice re-
establishes gut microbiota, prevents alteration in microRNA expression and restores gut barrier integrity
following alcohol and burn injury. Finally, the focus of Aim 3 will be on whether a shift in microbiome derived
metabolites (i.e., SCFAs and TMAO) alter microRNA expression and drive gut barrier disruption after alcohol
and burn injury. Our findings will help in identifying novel therapeutic agents/targets to maintain intestine
epithelial barrier and will be useful in developing therapeutic strategies for patients suffering from this
devastating injury.

Public health relevance
Project Narrative Burn injury is one of the leading causes of accidental injury in the United States, contributing to approximately one million cases and 40,000 hospitalizations each year. Burn patients who are intoxicated at the time of injury exhibit higher morbidity and mortality compared to those who are not intoxicated but sustained a similar extent of burn injury. Our studies aim to identify the role of gut bacteria and their metabolites in post-burn pathology and may help in developing better therapeutic strategies for this patient population.